Training Program in Pediatric Gastroenterology/Nutrition

PROJECT SUMMARY/ABSTRACT
This application is for the 9th consecutive renewal of the Ruth L. Kirschstein National Research Service Award
T32 Postdoctoral Research “Training Program in Pediatric Gastroenterology/Nutrition” at the University of
California, San Francisco (UCSF). More than 70% of the graduates of the UCSF Training Program in Pediatric
Gastroenterology/Nutrition remain productive researchers and academic leaders in their respective fields. The
Program aims to train talented and dedicated young physicians to become independent and productive scientific
investigators, and recent graduates have been successful in progressing along both academic career
development and biotechnology research pathways. These future scientists will research important health
problems, focusing on the causes, pathogenesis, and treatment of gastrointestinal, liver, and nutritional disorders
in infants and children. Preference is given to trainees committed to a 4-year training program, including 3 years
of research training in either Basic (T1 track), Clinical/Translational (T2 track), or, new for this renewal,
Computational Sciences (T3 track) Research mentored by established scientists. The key elements of the
proposed training are: (1) a mentored research experience, (2) scientific course work, (3) career development
workshops, (4) interdisciplinary experiences and (5) ongoing review and evaluation. Basic research experience
is supplemented with coursework, seminars, and inter-departmental retreats; trainees in clinical research
participate in the well-established Training in Clinical Research Program that includes a 1-year Advanced
Training in Clinical Research certificate, leading to a 2-year Master’s Degree in Clinical Research program;
similarly, Computational Sciences trainees have access to certificate and Master’s Degree programs integral to
training in this new field. Each trainee pursues an obligatory research project(s) supervised by experienced
preceptors. All trainees take courses in Responsible Conduct in Research, Research Rigor and Reproducibility,
Scientific Writing, and the Art of Lecturing. The trainee and research mentor determine additional course work
in the specific field of research. Entry requirements include a MD degree and 3 years of residency in clinical
pediatrics. Applicants with a PhD degree and defined career goals related to developmental gastroenterology or
nutrition are also eligible. Administration of the program is restructured to take advantage of the strengthened
Division of Pediatric Gastroenterology/Nutrition under the primary direction of Dr. Melvin Heyman, Co-Direction
of Dr. James Bayrer, associate direction from Drs. Philip Rosenthal and Emily Perito, and mentored assistant
direction from Dr. Sofia Verstraete. The quality of educational and research programs and activities are closely
monitored by trainee mentors, research preceptors, Internal Advisors, the Assistant Program Director, the
Associate Program Directors, the Program Director and Co-Director, and annual evaluations by distinguished
External Advisors. An increase from 4 to 5 training positions is requested.

Public health relevance
PROJECT NARRATIVE This Program is directly relevant to child health and development in training the next generation of scientists who will generate the advances essential for improving the quality of life and survival rates of children and adolescents with gastrointestinal, liver and nutrition-related disorders. Further, this training program represents an investment in the future of public health in general, as the multidisciplinary, intensive and innovative training provided by this Program will educate the leaders, teachers, and professional role models who will determine the direction and contributions of American medicine domestically and throughout the world, particularly as relates to pediatric gastroenterology, hepatology and nutrition.